GLUCOSE MALABSORPTION AND RAPID INTESTINAL TRANSIT IN CHRONIC DIARRHEA

This study tests the hypothesis that, in certain individuals, oral nutrient loads pass through the small bowel rapidly, leading to glucose malabsorption and rapid intestinal transit time.